Evaluating the Effectiveness of Mindfulness-Based Therapy for SMI Implemented in a Community Mental Health Setting

Serious mental illness (SMI), encompassing schizophrenia-spectrum and major mood disorders, has been
estimated to affect approximately 5.4% of the U.S. adult population each year. Research shows low rates of
evidence-based treatment being provided to patients with SMI. This is unfortunate, because evidence-based
psychological therapies have been shown to be effective for improving outcomes in SMI. One such efficacious
psychological intervention is mindfulness-based therapy (MBT), which integrates mindfulness practice with
cognitive-behavioral strategies to improve illness management. Previous trials conducted in the United
Kingdom have shown that MBT improves symptoms and functioning in community-based outpatients with SMI,
including in routine practice settings. In the U.S., most patients with SMI receive treatment at local community
mental health centers (CMHCs). However, patients in CMHCs often cannot access evidence-based therapies
like MBT due to the lack of trained staff able to provide these interventions. Further, previous studies of MBT
have been conducted exclusively outside the U.S. It is essential to confirm that MBT is effective when
delivered for patients with SMI in the U.S., and how it can be sustainably implemented in CMHCs where this
clinical population is commonly treated. Thus, we propose to test the effectiveness of MBT for SMI and study
its implementation in a typical CMHC setting. Additionally we will specify a certified training program in MBT for
frontline clinicians, given the differences between U.K. and U.S. healthcare systems. To speed translation to
clinical practice, we also will collect information from diverse community partners on implementation barriers
and facilitators to promote future uptake. We will randomize 160 patients with SMI (psychotic-spectrum and
major mood disorders) to receive treatment as usual (TAU) vs TAU plus MBT delivered by frontline clinicians in
a large, diverse CMHC. We will conduct blinded assessments at baseline and at 6- (mid), 12- (post), and 24-
weeks (follow-up). Consistent with an experimental therapeutics approach, we will examine potential
mechanisms of action (e.g., mindfulness skills), as well as collect implementation-focused quantitative and
qualitative data from our community partners (patients, administrators, clinicians). If found to be effective and
aided by a certified training program and the implementation data collected, MBT could be adopted as a future
evidence-based practice and integrated into the routine community care of patients with SMI, thereby reducing
health disparities.

Public health relevance
Project Narrative Individuals with severe mental illness often lack access to evidence-based mindfulness therapies in community mental health centers, even though mindfulness been shown to improve symptoms and functioning, and patients and clinicians express interest in this approach. If found to be effective from this trial, mindfulness- based therapy could be adopted in the U.S. as an evidence-based practice and integrated into the routine community care of patients with severe mental illness. This project also will develop a more widely- disseminable training program to certify clinicians in the treatment approach to speed its uptake to other community mental health centers nationally.